GL9501--LONG TERM SAFETY AND TOLERABILITY OF GL701 IN PATIENTS WITH SLE

This research study is designed as an open label safety study of GL701(DHEA) in patients who have stable systemic lupus erythematosus (SLE), who have successfully completed a previous Genelabs GL701 protocol, and who wish to continue treatment with DHEA. GL701 will initially be given in a dose of 200 mg/day, which may be decreased to 100 mg/day for patients based on their intolerance of the drug. The goals of this research study are to evaluate the long-term safety and tolerability of GL701.